The taste of ribonucleosides: The molecular and cellular basis underlying chemosensory detection of previously unknown macronutrients

Insects are the most abundant class of animals, next to vertebrates. For example, the biomass of
termites alone equals that of humans, the most abundant mammal. There are about 1 million named insect
species and approximately another 5 million yet to be classified, compared to about 66,000 species of
vertebrates. While overall beneficial to our ecosystem, some insects have considerable negative impact on
human health. Disease vectors, mostly flies and mosquitoes, are major transmitter of microbes that cause
devasting human diseases, including yellow fever, dengue, malaria and zika. These insect vectors kill close
to a million people each year, sicken hundreds of millions more and incur billions of dollars annually in costs
for treatment and lost productivity. Other insect species are agricultural pests and consume crops and fruits
of cultivated plants, leading to famine in many parts of the world. In light of these facts, a better
understanding of insect biology and behavior, in particular chemosensory behavior, is paramount for
developing specific and effective strategies for population control of harmful pests.
Drosophila melanogaster, with its array of experimental tools, is uniquely suited to uncover the basic
principles underlying these behaviors. Like mammals and other insects, Drosophila depend on
chemosensory systems to navigate their external world appropriately. The sense of taste is particularly
important to identify food sources and avoid harmful chemicals. To assure that all essential food chemicals
are consumed, insects have evolved appetitive taste receptors for the three major macronutrients, proteins,
carbohydrates and fats. Intriguingly, Drosophila larvae, in contrast to adult flies, can also sense
ribonucleosides and RNA in their food. These chemicals represent an essential resource required to support
rapid growth and survival during the fast-growing larval stages. Larvae employ a small number of closely
related taste receptors, the Gustatory Receptors (Grs) 28 to detect these chemicals. The Gr28 genes are
among the most conserved insect taste receptor genes, homologs of which are found in all insect genomes,
from flour beetles to honeybees to mosquitoes. These observations suggest that the Gr28 genes have a
conserved role, namely to detect RNA and ribonucleosides in insects. Remarkably, some of the Gr28 genes
have been implicated in temperature and light sensing, expanding their role to sensory pathways beyond
taste. Thus, an in-depth understanding of the function of receptors for RNA and ribonucleosides is of
considerable interest, especially because they are broadly conserved in diverse insect species, from
disease vectors (mosquitoes and flies), to agricultural pests (beetles, grasshoppers) and ecologically
beneficial pollinators (honeybees). Exploiting the ability of insects to sense RNA and ribonucleosides via
specific taste receptors may provide new opportunities to develop strategies for control of harmful insects.

Public health relevance
This research is relevant to public health because of its conceptual novelty and its broad impact on chemosensory research. It is proposed to examine the molecular and cellular basis of a novel taste modality in Drosophila larvae, the taste of RNA and ribonucleosides, which are essential nutrients during the fast- growing larval life stages. The taste of RNA is conserved across a range of insect species, including disease transmitting mosquitoes, and therefore, elucidating the mechanism of this taste modality may lead to new approaches and strategies for insect pest control.